The Study of Muscle, Mobility and Aging with Knee OA

Deterioration of musculoskeletal tissues with age results in osteoarthritis, reduced mobility, and increased
disability. Osteoarthritis (OA) frequently affects the knee and is the leading cause of disability worldwide. Poor
muscle characteristics are associated with knee OA (KOA) and cross-sectional comparisons of healthy
controls and KOA subjects show differences in muscle composition, quadriceps muscle strength and power. A
few, small cross-sectional studies have also rigorously investigated muscle qualities associated with reduced
mobility in older adults, independent of KOA, and reported reduced muscle mass, decreased ability to generate
ATP, denervation, oxidative damage, and decreased autophagy. However, these clinical studies have been
small, only cross-sectional, and often did not include individuals at risk for immobility or documented KOA. How
these muscle qualities change with KOA is not known and represents a roadblock to understanding reduced
mobility and increased disability in KOA. The NIA/NIH recently funded a Study of Muscle, Mobility and Aging
(SOMMA), which just began enrolling 875 intermediate functioning, ethnically diverse women and men age
>=70yrs. at two centers. The SOMMA study aims to 1) understand the contributions of skeletal muscle mass,
energetics, and key properties of muscle tissue from biopsies to major immobility and disability; and 2) produce
a unique bank of muscle tissue, blood, gene expression data, and clinical phenotyping to be used by the
scientific community. We propose to obtain knee radiographs at the first SOMMA follow-up visit to understand
the contributions of skeletal muscle mass and composition that leads to reduced mobility and disability in KOA
subjects and if this differs from subjects without KOA. The Specific Aims are: Aim 1a: We will use state of the
art measurements to test the hypothesis that muscle properties (strength, mass, composition, energetics-
ATPMax) differ in subjects with KOA compared to individuals without KOA, and will perform separate analyses
for radiographic KOA (regardless of knee pain) and symptomatic KOA in persons with radiographic OA and
frequent knee pain. Aim 1b: We will use muscle properties (strength, mass, composition, energetics-ATPmax)
to define muscle phenotypes to test the hypothesis that there are muscle phenotypes associated with KOA and
KOA and pain. Aim 2: We will test the hypothesis that persons with radiographic KOA and symptomatic KOA
will have worse mobility and functional outcomes (400m walking speed and Mobility Assessment Tool- short
form, MAT-sf Disability) than those without KOA and that this difference is mediated in part by specific muscle
characteristics. Our goal is to determine what combination of muscle properties are associated with function in
KOA subjects and use the information to design novel muscle-based treatments to help subjects with KOA.

Public health relevance
The proposed research is relevant to the public’s health as nearly 40% of subjects over the age of 70 years will develop osteoarthritis (OA) of the knee, and this results in both a reduction in mobility and an increase in disability. Recent studies have shown that muscle strength, power and composition are different in knee OA subjects compared to subjects without knee OA. Upon completion of this research we will determine which combination of muscle properties predict declines in lower extremity function in elderly individuals with and without radiographic and symptomatic Knee OA. These novel muscle properties will be targets for novel interventions to reduce lower extremity disability in Knee OA subjects.